CORE--PHARMACOKINETICS AND ASSAY DEVELOPMENT

This core service 9002, Pharmacokinetics and Assay Development, will provide developmental and analytical support to projects involving blood levels of anticancer agents used to treat cancer. The specific aims include developing sensitive and precise HPLC assays for: 1) new anticancer agents including taxotere, combretastatin a-4, azonafide EL- 53, imexon, adozelesin and a sulofenur analog to be tested in (Project 19) 2) new antitumor agents based on peptides for a) B-cell lymphomas or antagonists of matrilisin (Project 28) or b) for newly-identified inhibitors of cell-signalling molecules (Project 301) 3) characterize the AUC for three new agents used at LD50 doses in the mouse to apply the Collins dose-escalation method in humans (Project 19) and 4) characterize the clinical pharmacokinetics of DNA intercalators combined with cyclosporine A as a resistance chemomodulator in patients with refractory malignancies (Projects 29 + 19). Two analytical laboratories (Dr. Peng and Dr. Dorr) will work on these aims to provide rapid service to each of the projects. A pharmacokinetic data base will be developed for each agent by an interaction with the Biometry Core 9001. Overall, this core will help to guide the clinical development of new pharmacologic treatments of cancer.